Roles of small RNAs in guarding germ cell genomes

DESCRIPTION (provided by applicant): It is essential that the genome be passed faithfully from parents to their offspring. Threats to faithful genome transmission come from limitations on the fidelity of replication, errors in chromosome segregation, and from the deleterious activity of parasitic genetic elements, transposons, which propagate by increasing their copy numbers in germ cell genomes. The challenge of transposon control is formidable. In Drosophila, more than 200 different elements are distributed among highly divergent families. These elements use different mobilization strategies and share no universal proteins or cofactors. Thus, the host must somehow discriminate this diversity of elements from protein coding genes and selectively silence the former. Over the past 6 years, we have come to understand that the piRNA pathway plays a critical role in reproductive tissues, embodying an essential defense mechanism against mobile genetic elements. Studies, mainly in Drosophila and mice, have established a molecular framework for how the piRNA pathway operates and have implicated a growing list of protein cofactors in its various stages. While we have produced a coarse model for piRNA production and for the mechanisms by which the pathway silences transposons, we are only just beginning to understand many of the molecular events that form the mechanistic basis of this innate immune system Our goal in this proposal is to address three key, outstanding issues. First, we wish to understand how the definition of a transposon is established in the form of a piRNA repertoire. This entails deciphering the regulation of piRNA generative loci, the mechanisms which mark RNAs to be processed into piRNAs, and the mechanics of piRNA biogenesis. Second, we will uncover the biochemistry of target repression by Piwi protein/piRNA complexes at both the transcriptional and post-transcriptional levels. Third, will probe the functions of maternally inherited piRNAs and their roles in germ cells and in the soma. By accomplishing these aims, we will contribute to the understanding of one of the most deeply rooted biological imperatives, the need to conserve the integrity of the germ line!

Public health relevance
PUBLIC HEALTH RELEVANCE: It is essential that the genome be passed faithfully and intact from parents to their offspring. We have discovered a mechanism by which the genomes within the germ cells of virtually all animals are protected against damage by parasitic genetic elements. The goal of this proposal is to understand how this mechanism operates and to probe the full range of its biological functions. __SpecificAimsTextDelimiter__ Specific Aims Transposons represent one of the most basic embodiments of the host-parasite relationship1. Their drive is to propagate in the germ lines of their host, while the host must, in turn, strive to restrain the parasite. Loss of transposon control has dramatic consequences. Not only does unrestrained transposon activity result in a cumulative mutational burden, but also the failure to control even a single mobile element can lead to sterility.2,3 The challenge of transposon control is formidable. In Drosophila, more than 200 different elements are distributed among highly divergent families4. These elements use different mobilization strategies and share no universal proteins or cofactors. Thus, the host must somehow discriminate this diversity of elements from protein coding genes and selectively silence the former. In the past few years, we and others have begun to unravel an intricate, small RNA-based immune system, the piRNA pathway, that protects animal reproductive tissues from the deleterious effects of transposon mobilization. piRNAs partner with Piwi-family Argonaute proteins, serving as sequence-specific guides to direct Piwi-RISCs to silence transposon targets5-8. Thus, the sequence content of piRNA populations defines the set of mobile elements over which an organism has gained control. "Primary" piRNAs are processed directly from long, single-stranded transcripts of discrete genomic loci, termed piRNA clusters7. These are essentially transposon graveyards comprising tens to hundreds of kilobases of transposon fragments, often derived from ancient insertions that have diverged from the consensus. These clusters produce a repertoire of small RNAs that include hundreds of thousands of distinct species. Clusters can also adapt to new transposon challenges. As a novel unrestrained element propagates through the genome, a copy will eventually lodge in a piRNA cluster and begin contributing its sequence to primary piRNA populations, which in turn enables the piRNA pathway to silence all insertions of the element in trans9. Flies employ three Piwi family proteins. Piwi is essential both in the nuclei of germ cells and somatic follicle cells, while Aub and Ago3 operate only in the germ line cytoplasm.7,8,10-13. Primary piRNAs are loaded into Piwi and Aub. While the mechanisms by which Piwi functions are just beginning to emerge (see Progress Report), Aub cleaves transposon mRNAs in the cytoplasm. This leads to the production of a new sense piRNA loaded into Ago3, with its 5' end at the cleavage site. Upon cleavage of a transcript with antisense transposon content, most often from a piRNA cluster, Ago3 generates a new antisense piRNA, equivalent to the one that initiated the response. This adaptive amplification loop is termed the ping-pong cycle and produces "secondary" piRNAs while consuming transposon mRNAs7,8. Piwi and Aub complexes are also maternally deposited and provide key, epigenetic information to progeny regarding maternal transposon loads11,14,15. At a minimum, they appear to prime the ping-pong cycle in progeny in a manner key to the control of at least some elements. Work from the past few years has provided a coarse model for piRNA production and for the mechanisms by which the pathway silences transposons; however, we are only just beginning to understand many of the molecular events that comprise this innate immune system. The overall goal of this proposal is to address key, outstanding questions in three broad areas that are embodied in its Specific Aims. Aim 1. To understand the mechanisms of piRNA biogenesis. The piRNA repertoire forms the molecular definition of what an animal views as a transposon. Thus, understanding the mechanisms that fate certain transcripts to generate piRNAs is of critical importance. We will investigate the regulation of piRNA cluster expression, the signals that instruct processing of its transcripts into piRNAs, and the biochemical mechanisms of primary piRNA biogenesis, partly building upon insights from the last funding cycle. Aim 2. To understand how piRNAs silence transposons. In the soma, the nuclear Piwi protein is sufficient for repressing transposons at the level of their transcription (see Progress Report). Yet in the germ line, Piwi, Aub, and Ago3 are all essential, indicating a need for both transcriptional (TGS) and post-transcriptional (PTGS) silencing. We will work to understand the precise mechanisms by which Piwi affects chromatin, and in turn, gene expression and ask whether these are shared between somatic and germ line lineages. We will also endeavor to understand why PTGS and TGS are essential in germ cells and how these processes interrelate. Aim 3. To understand the role of maternally deposited piRNAs. piRNAs bound to Piwi and Aub are maternally deposited, and their transmission is essential for the silencing of at least some elements.14 However, the full range of activity of these complexes has not been addressed in detail. We will selectively eliminate maternally deposited Aub or Piwi and systematically investigate impacts on both the germ line and the soma of progeny.